Modulation of ITK signaling for sustainable adoptive T cell therapy

Project Summary/Abstract
CAR-T cell therapy has demonstrated success in curing B cell (CD19+) malignancies and has shown
promise in treating lupus. However, the cytotoxic and short-lived nature of CAR-T cells results in severe side
effects of immunopathology and reduces the therapeutic values of this costly therapy. There is an urgent need
for novel strategies to elicit potent and persistent tumor-specific effector and memory T cell responses and
minimize off-target toxicity in CAR-T therapy. This makes our work highly significant. T cell development,
function and homeostasis are regulated by T cell receptor (TCR) signals as well as cytokines and are suggested
to be proportional to TCR signal strength. Yet, excessive TCR activation and cytokine stimulation can trigger
excessive cytotoxic T cell activation causing immunopathology, with rapid exhaustion of anti-tumor immunity.
Our preliminary data show that IL-2-inducible T cell kinase (ITK), a key regulator of TCR signaling, negatively
regulates CD8+ T cell homeostatic expansion and effector memory functions. The absence of ITK resulted in
enhanced effector cell fate programming, antigen sensitivity and anti-tumor immunity of CD8+ T cells in mice.
Our pilot experiments show that deletion of ITK in human CAR-T cells also resulted in improved production of
CAR-T cells that are significantly more sustainable in vitro, and have adequate tumor killing activity and minimal
tissue cytotoxicity. We hypothesize that ITK signaling can be modulated to promote CAR-T cell expansion,
survival and long-term anti-tumor activity, while limiting the effector cytotoxicity. We propose two specific
aims: (1) determine ITK's role in CAR-T cell expansion, function, and safety; and (2) develop a novel class of
CAR molecules containing modulatory domains for ITK signaling inhibition. Our work is innovative, supported by
exciting preliminary data that challenge conventional thinking. Validating this hypothesis will unveil ITK's role,
relevant signaling pathways, and biomarkers in CAR-T cell production, safety, and efficacy. We also propose
developing a novel class of CAR molecules that contain TCR signaling modulators, which will further our
understanding of CAR-T cell signaling and enable a handy production of safe, effective and sustainable CAR-T
cells. Completion of the proposed work will add to our knowledge of new molecular principles for the design of
improved CAR-T cell production, safety and therapeutic efficacy. Our pre-clinical results are directly transferable
to understanding human CAR-T cell biology and have the potential of improving of CAR-T therapy.

Public health relevance
Project Narrative CAR-T cell therapy has been proven effective in treating hematological malignancy and autoimmunity caused by B cell abnormality, but the cytotoxic and short-lived nature of CAR-T cells have become a major hurdle to this therapeutic strategy. We aim at improving longevity while reducing the cytotoxicity of CAR-T cells, by deletion or inhibition of the TCR signaling mediator ITK, which is a negative regulator of T cell survival and long- term memory functions. A better understanding of the role of ITK in CAR-T cell development and function, and new approaches to targeting ITK in CAR-T cells, will improve CAR-T cell production, therapeutic sustainability, and help expanding the therapeutic options for patients with cancer and/or autoimmune disorders.